SEER TRAINING WEBSITE, NEW DATA ITEM FEASIBILITY STUDY, AND SEER ADVANCED TOPICS FOR REGISTRY PROFESSIONALS WORKSHOP TECHNICAL AND LOGISTICAL SUPPORT

TECHNICAL AND LOGISTICAL SUPPORT for
-SEER TRAINING WEBSITE,
-NEW DATA ITEM FEASIBILITY STUDY,
-AND SEER ADVANCED TOPICS FOR REGISTRY PROFESSIONALS WORKSHOP